Decoding the Multifactorial Etiology of Neural Network Dysfunction in Alzheimer's Disease

SUPPLEMENT – SUMMARY
Tau contributes to Alzheimer’s disease (AD) and many other brain diseases. However, it is uncertain how tau
causes neuronal dysfunction and degeneration, in part because experimental models are not optimized to
compare the relative pathogenicity of different tau species in disease-relevant contexts. Mutations in MAPT, the
gene encoding tau, cause frontotemporal lobar degeneration (FTLD) instead of AD. In contrast, the rare A152T
variant of tau increases risk for both types of diseases. These associations merit further exploration, especially
as models expressing FTLD-mutant tau are widely used to study tau in AD and to develop novel AD treatments.
Clinical AD onset is preceded by abnormal accumulations of amyloid-b (Ab) peptides in brain, and many AD
patients have at least one apolipoprotein (apo) E4 allele, the most important genetic risk factor for AD. Therefore,
Project 3 will generate new mouse models combining human Ab and apoE4 expression with near-physiological
levels of human tau that is wildtype, as in most AD patients, or carries the A152T substitution, which increases
AD risk. Comprehensive functional, pathological, and transcriptomic analyses of the new models, to be carried
out in collaboration with Projects 1, 2, and 4 and Core B, should yield new insights into differential effects of
these tau species and their roles in the pathogenesis of dementia. Project 3 will also investigate whether tau
species that increase AD risk or cause FTLD differ in their effects on the integrity and functions of neurons and
neural networks. Until we know which forms of tau are most pathogenic in different conditions, the most
pragmatic therapeutic approach to tau in our view is partial reduction of overall tau levels, which is well tolerated
and has benefits in more conventional models. We will therefore use tau-targeting antisense oligonucleotides to
reduce human tau levels in models co-expressing human Ab and apoE4. Single-nucleus/single-cell
transcriptomic analyses will be used to identify cell-type-specific gene expression changes as well as novel
molecular and cellular mechanisms that may mediate pathogenic effects of tau or beneficial effects of tau
reduction. These analyses will help Projects 1 and 2 distinguish between pathogenic mechanisms of apoE4 and
Ab that do or do not depend on tau. They could also identify novel molecular and cellular mechanisms that
mediate tau sequence-specific effects. The requested supplement will allow a postdoctoral scholar from a
background that is underrepresented in the health-related sciences to contribute to the experiments proposed in
Project 3 and, at the same time, to benefit from training within the larger context of this AD-focused
interdisciplinary program.

Public health relevance
SUPPLEMENT – NARRATIVE This program project brings together leaders in disease-focused neuroscience, systems biology and bioinformatics to address important problems in Alzheimer’s disease (AD) research that are both unresolved and understudied. The experiments proposed in Project 3 and the larger context of this interdisciplinary program would give a talented minority candidate the opportunity to help elucidate molecular and cellular mechanisms of neural network dysfunction and cognitive decline in AD and to promote the development of novel therapeutic strategies to block them. Sharing the highly diverse data sets we will generate and disseminating the novel integrative approaches we plan to develop for their analysis could also enhance the progress of many other groups working in AD research or biomedicine in general.